Computation and Development of New, Enabling Synthetic Methods

PROJECT SUMMARY/ABSTRACT
Summary
The overall objective of this research program is to develop analyses, tools, and methods to
achieve new, more effective reagents, catalysts, and biological ligands.
One focus will be on state-of-the-art computation methods to understand stereoselectivity,
chemoselectivity, and reactivity at the molecular level with the aim of designing new, more
effective reagents, catalysts, and biological ligands. The control of selectivity and reactivity are
essential features of efficient synthesis, yet our molecular level understanding of how fundamental
interactions perturb these aspects is only rudimentary. Further, many aspects of how these same
fundamental interactions govern binding in a biological context are incompletely understood.
Another focus will be on oxidative coupling of fragments via C-C, C-O, and C-N bond formation
by means of C–H activation chemistry. Catalyst libraries will be designed for study of biomimetic
reactions using two guiding principles: 1) matching catalyst oxidation potentials with the oxidation
potentials of the substrates under consideration and 2) selecting metals that can utilize oxygen to
regenerate the catalytic species. These libraries will be deployed in a high-throughput microscale
format to discover reactivity patterns heretofore unimagined. From the data obtained, reaction
“profiles” will be constructed and new inferences about reactivity, selectivity, and mechanism will
be made, which will be tested experimentally.
The fundamental hallmark of this proposal is the ability to access new reaction patterns to
construct important organic structures in an efficient and rational manner. Computation and
mechanistic understanding gives us the tools to solve problems and posit hypotheses. High
throughput microscale experimentation permits rational hypotheses to be interrogated broadly
and to facilitate optimization of the many interdependent variables in the possible reaction space.
Relevance
The fundamental hallmark of this proposal is the ability to design new reactions and catalysts
via computation and mechanistic study. The goal is to construct important organic structures in
an efficient and rational manner. New synthetic methods greatly increase access to untapped
chemical space, leading to materials and pharmaceuticals that benefit society. To achieve this
goal, investigations will focus on obtaining an improved understanding of reactivity and selectivity.
The development of new oxidative coupling chemistry is a particular focus due to increases in
efficiency from lower step counts and smaller waste streams. The challenge in this area is
selectivity in any given transformation due the numerous C–H bonds present in a typical organic
molecule. Use of biomimetic processes leads to bioactive natural products and natural product-
like cores, desirable entities in medicinal chemistry. Invaluable training, absent outside of
industrial settings, will be afforded to graduate students and other coworkers.

Public health relevance
PROJECT NARRATIVE The proposal will develop analyses, tools, and methods, both computational and experimental, to achieve new, more effective reagents, catalysts, and biological ligands. New synthetic methods greatly increase access to new materials and pharmaceuticals that benefit society. The understanding of how small molecules bind to biomacromolecules is a key driver in drug design.